Admin Core

Administrative Core – Project Summary/Abstract
Many patients and survivors of cancer suffer from side effects of treatment both during and after the completion
of cancer therapy. The COBRE Center for Studies of Host Response to Cancer Therapy supports
investigators from various disciplines who perform research to understand the mechanisms by which cancer
therapy causes side effects, identify new methods for early detection, and develop novel strategies for
preventing or treating side effects. The purpose of the Administrative Core (Core A) is to provide
oversight of the Center and the administrative support required to build and maintain a self-sustaining
research center of excellence. Core A aims to maximize opportunities for investigators to succeed, ensure
technical core facilities enhance the research infrastructure for Center members and other researchers at the
institution, and promote interactions and synergy within the Center and with other research units in the
institution. Core A will provide an efficient, integrated administrative infrastructure for the COBRE Center,
which includes financial oversight and measures for effective communication within and among the Center
members, technical cores, and Advisory Committee (Specific Aim 1). Core A will oversee the Center’s Pilot
Project Program, which will annually solicit applications and select pilot projects that increase the Center’s
research portfolio (Specific Aim 2). Lastly, Core A will monitor the Center’s progress toward becoming a self-
sustaining center of excellence and implement measures to monitor and ensure success (Specific Aim 3).
Core A will be responsible for systematic and objective evaluations of research progress, external funding
obtained by Center members, scientific advising and faculty development programs, and functions of the
technical cores. Based on the outcome of the evaluations and in communication with the Advisory Committee,
activities will be adjusted or newly implemented to ensure the Center and its programs stay on course.
This strategy will ensure the long-term success of the Center as an independent but well-integrated
investigative unit on campus with a vibrant and synergistic research environment that
comprehensively addresses the short-term and long-term effects of cancer therapy.